THE COVID 19 SERVICES CATALYZE TRANSLATIONAL RESEARCH FINDINGS INTO PUBLIC HEALTH CHANGES TO ADDRESS THE NOVEL CORONAVIRUS PANDEMIC THROUGH IMPLEMENTATION OF STANDARDIZED SEROLOGY TESTING FOR ITS INTE

The following support shall be provided for Therapeutic Development Branch:
• Continuation of the "Integrated Data Resource for Rare Diseases" working with Advanced Biomedical Computational Science at Leidos Biomedical Research, Inc.;
• Assay validation and non-GMP and GMP manufacturing of batches of drug substance and drug product;
• Stability studies to support projects with GMP and / or non-GMP products;
• Biodistribution / imaging and pharmacokinetic studies;
• Consulting services for development of bioanalytical methods;
• Regulatory services to support preclinical and / or clinical-stage projects;
• Electron microscopy studies;
• Gene expression and proteomic data analyses and cell-based screening studies;
• Proteomic profiling, cell-based efficacy studies, and clinical trials for canine comparative oncology;
• Laboratory animal support.